Behavior Change in Health and Saving

DESCRIPTION (provided by applicant): This application would create at the NBER a Roybal Center on behavior change in health and saving. Through experimental pilot projects and the coordination and planning of a centralized management core, the Center will seek out opportunities for translating basic findings from our academic research in the economics of aging into practical real-life applications that improve health and economic well-being at older ages. The Center will develop and undertake a series of pilot projects to study how scalable institutional and policy interventions affect behavior in the domains of health and savings. A particular goal is to translate successful behavioral interventions already developed and successfully applied in the domain of retirement savings to the domain of health behavior. The experimental interventions supported by the Center will cover a range of health-related behavior, multiple aspects of financial behavior, a diversity of channels thrther with a range of other research on saving behavior, health behavior and behavioral economics taking place at the NBER, will be coordinated under the umbrella of a Roybal Center management core.

Public health relevance
Drawing on a large foundation of ongoing research activity on health, saving and other aspects of wellbeing, and on a series of specific experimental pilot projects, the Roybal Center will translate basic research findings in the economics of aging into practical institutional and policy interventions that can improve health and economic wellbeing at older ages.